Improving in vitro preantral follicle development using novel bioengineered culture systems and pre-theca-like cells as a strategy for assisted reproduction

1 PROJECT SUMMARY
2 Infertility has become a fundamental quality-of-life issue for young girls and women who have undergone
3 gonadotoxic cancer treatment. A highlighted approach to preserve fertility is capitalizing on the abundant
4 population of primary follicles found in the ovary without auto-transplanting possibly malignant tissue. However,
5 success rates of developing these follicles in vitro to yield mature oocytes is inefficient and limited in humans
6 and nonmurine model mammals. The long-term goal of this work is to establish a culture system to support the
7 study of in vitro primary follicle growth in the bovine as a translational model for human folliculogenesis. The
8 central hypothesis is that a biomimetic culture system using poly(ethylene glycol) (PEG) with degradable
9 crosslinker peptides and co-encapsulation with mesoderm-like cells (MLCs) that can give rise to theca-like cells
10 will better promote the primary follicle development. The rationale behind this work is that a dynamic three-
11 dimensional (3D) culture system that allows follicle-driven matrix degradation and is supplemented with cells
12 similar to the ovarian stroma (including theca cells) will recapitulate the native ovarian environment and better
13 support long-term folliculogenesis. The central aim of this proposal is to examine the ability of mesoderm-like
14 cells (MLCs) to become theca-like cells and promote development of bovine primary follicles comparable to the
15 inclusion of dissociated ovarian cells in a PEG hydrogel culture system. Previous research has shown that feeder
16 cells, such as adipose-derived stem cells, aid in the development of mouse preantral follicles in vitro. However,
17 MLCs reflect a cell identity similar to the mesoderm lineage, which is the developmental origin of ovary.
18 Additionally, they express follicle-responsiveness genes that are known to be essential for theca cell
19 differentiation and recruitment. Therefore, we hypothesize their addition in preantral follicle culture will add to the
20 creation of a microenvironment that better mimics the natural ovary, thus enhancing support of bovine preantral
21 follicle development. The novel aspect of this work is the translation of a bioengineered culture system, that has
22 only been used in short-term mouse in vitro follicle culture, to a new organism known to better model the long
23 and complex process of human folliculogenesis. Moreover, here we test the inclusion of stemness-derived cells
24 that express genes known to be responsive to follicle-secreted factors to create the theca-cell counterpart, thus
25 further emphasizing the novelty of the project. The significance of this work is that it will contribute to the
26 advancement of methods to grow primary follicles from a large mammal model species like the bovine, which
27 will be more directly translated into human. Overall, this project provides insight on using a culture system and
28 supplemental cell source that can help in the overall study of folliculogenesis from the primary stage such that
29 we can 1) better understand this multifaceted process and 2) ultimately create a broad fertility preservation option
30 for both young girls and women.

Public health relevance
PROJECT NARRATIVE Fertility preservation using ovarian preantral follicles has become a promising alternative for young girls and women undergoing gonadotoxic cancer treatment and facing infertility; however, developing human preantral follicles to yield oocytes in vitro and avoid auto-transplanting tissue has only been recently achieved and very inefficient. Creating a three-dimensional in vitro culture system complemented with theca-like cells to grow bovine preantral follicles, a model species that resembles human folliculogenesis and ovary biology more closely than the mouse, would permit the study of preantral follicle development in a microenvironment more similar to the native human ovary. By examining the potential of this novel and dynamic in vitro culture system to develop preantral follicles long term in the bovine, this research will help us better understand human preantral folliculogenesis and potentially offer a comprehensive fertility preservation option.